Leveraging CDISC innovative approaches and emerging technology to expedite development of open, end-to-end tobacco standards to facilitate regulatory submission, review and decision making.

Project Summary – CDISC Tobacco Standards Project
CDISC is well positioned to assist FDA-CTP in achieving all four overarching program strategic
goals and program objectives listed in RFA-FD-22-022. CDISC, for over 20 years, has supported
open, consensus based, standards development and has maintained and promoted a well-
defined data standards governance function regulated by CDISC COP-001 Standards
Development [7]. All CDISC standards development follow this rigorous process to
ensure quality and fitness for use as well as encourage the wide adoption of the standards.
Leveraging deep previous experience and the standards development process mentioned above,
the CDISC Standards Development Team will engage stakeholders in the
publication of a Tobacco Implementation Guide v1.0, conformance rules and
development and
machine-readable
Biomedical Concepts (BCs) for core tobacco clinical research concepts. Conformance
rules, provide a critical quality check in ensuring study data conform to CDISC standards and BCs
can result in a significant step towards end-to-end automation and traceability. CDISC will ensure
alignment and harmonization with the CDISC Study Data Tabulation Model (SDTM) for FDA
electronic submissions, Clinical Data Standards Harmonization (CDASH), and ADaM. These
standards will be freely available on the CDISC website.
The CDISC Data Science team will update the CDISC Library model and software to load and
generate outputs for BCs, new standards content, ready-to-implement metadata, and executable
representations of conformance rules and represent metadata in ODM and Define-XML and
develop a model to include TAUG/Foundational content into CDISC Library [35] that includes the
ability to generate ready-to-implement metadata and normative standards metadata content.
CDISC will also develop educational content and make it available to implementers and utilize
multiple channels of dissemination/outreach to communicate the release of the Tobacco
Implementation Guide v1.0 and the new Library features to the broader research
community. CDISC also proposes to leverage the FHIR-CDASH mapping to enable CTP to
explore application of Real-World Data (EHR). CDISC’s catalogue of existing standards, along
with the innovative approaches and technology outlined in this application will help to position
FDA-CTP to move toward optimizing activities that advance tobacco research, regulatory
submission, review and decision making and post marketing surveillance of tobacco products.

Public health relevance
Project Narrative – CDISC Tobacco Standards Development Project Project Narrative Leveraging previous experience and a well-established governance and open consensus-based standards development process CDISC will engage stakeholders in the development and publication of a Tobacco Implementation Guide v1.0 that includes conformance rules, machine- readable Biomedical Concepts (BCs) for core tobacco clinical research concepts and make these freely available on the CDISC website while ensuring alignment with the CDISC Study Data Tabulation Model (SDTM), Clinical Data Standards Harmonization (CDASH), and the Analysis Data Model (ADaM). CDISC will also update the CDISC Library model and software to load and generate outputs for BCs, new standards content, ready-to-implement metadata, and executable representations of conformance rules, represent metadata in ODM and Define-XML and develop a model to include TAUG/Foundational content into the CDISC Library [35] that includes the ability to generate ready-to-implement metadata and normative standards metadata content. CDISC will develop educational content and make it available to implementers and utilize multiple channels of dissemination/outreach to communicate the release of the Tobacco Implementation Guide v1.0, Model v1.0 and the new Library features to the broader research community.